Fine-mapping psychiatricdisease variants that affect post-transcriptional gene regulation

PROJECT SUMMARY
Neuropsychiatric disorders (NPD) such as schizophrenia (SZ), autism spectrum disorders (ASD) and bipolar
disorders (BD) are remarkably common, with SZ alone affecting nearly three million Americans. Despite more
than fifty years of research, no cures exist for these conditions and the standard of treatment remains
unsatisfactory. Genome-wide association studies (GWAS) indicate that, in addition to highly penetrant rare
mutations, NPD risk also reflects the impact of hundreds of common single nucleotide polymorphisms with small
effect sizes. A major challenge in the field has been illuminating the pathways connecting these genetic variants
(the vast majority of which fall in non-coding sequences) to target genes and causal cellular phenotypes. To
understand how these myriad risk loci causally contribute to disease risk, it is essential to screen for putatively
causal variant(s) and determine how they influence gene expression, which has been shown to be cell-type
specific, as well as cellular function. Recent evidence has emerged indicating a substantial contribution of RNA
splicing variation to heritability across many complex genetic diseases, including SZ. Based on our preliminary
analyses and the work of others, we hypothesize that a substantial proportion of NPD GWAS loci exert their
pathogenic effects on neuronal function by impacting RNA: its structure, modifications, protein interactions and
splicing. To test this, we will apply novel tools and machine learning methods to predict and quantify RNA splicing
in the largest SZ, ASD and BD GWAS, in order to predict splicing quantitative trait loci (sQTLs, Aim 1). To confirm
true effects on exon inclusion independently in glutamatergic and GABAergic neurons (i.e., the major cell-types
impacted in NPD), up to several thousand of the predicted splice variants will be tested by a massively parallel
reporter assay, MaPSy (Aim 2). Finally, in order to evaluate the cell-type-specific impact of putative causal sQTLs
identified in Aims 1 and 2 on neuronal maturation and synaptic function, we will use CRISPR gene editing to
engineer these mutations within human induced pluripotent stem cell (hiPSC)-based models of both neural cell
types (Aim 3). Our overarching goal is to map and functionally evaluate the NPD-GWAS loci that impact
alternative splicing and neuronal function. Our work may impact the field by delivering new insights into the role
of common variants in NPD pathophysiology, which could inform ways of improving diagnostics, predicting
clinical trajectories, and developing novel therapeutic interventions.

Public health relevance
PROJECT NARRATIVE The causal role of neuropsychiatric disease risk variants putatively involved in RNA splicing on neuronal function has not been fully explored. By combining genetic fine-mapping, machine learning methods, massively parallel reporter assays, CRISPR-genetic engineering, and human induced pluripotent stem cell models, we propose to discover neuropsychiatric risk alleles predicted to impact alternative splicing and empirically test their molecular and functional impact in neurons. By better understanding the role of common variants in disease risk, we hope to improve diagnostics, predict clinical trajectories and develop novel therapeutic interventions.